Investigating Student-Level Outcomes of Equity-Focused Implementation Mapping in a Cluster Randomized Trial to enhance the impact of Universal School Meals

PROJECT ABSTRACT
The overall goal of this R03 award is to provide Gabriella McLoughlin, PhD, MS, with funding to investigate the
impact of an equity-focused implementation strategy on participation and uptake of Universal School Meals
(USM) among the students most at risk for food insecurity and obesity, building on her current K01 award.
Childhood food insecurity and obesity inequities have been exacerbated in recent decades, such that children
from racial and ethnic minority and low-income backgrounds are most at risk, increasing the marginalization
they face and unequal opportunities to accessing healthy and affordable foods. Multiple factors, such as
increased food insecurity resulting in a low-quality diet, contribute to this increased threat. Since children and
adolescents consume over half of their energy intake at school, providing free nutrient-rich breakfast and lunch
to low-income youth through Universal School Meals (USM) is a key policy approach to addressing obesity
inequities. Adoption of USM is linked with reductions in obesity risk for low-income students, improved diet
quality, reduced food insecurity, and enhanced academic achievement. Unfortunately, evaluation of USM so
far has focused mainly on school-level aggregate outcomes, potentially masking inequities in participation
among students most at risk for food insecurity and obesity. Thus, the purpose of this R03 award is to
investigate whether an equity-focused implementation strategy improves uptake of USM among students who
are most at risk for food insecurity and obesity through a multi-method approach. The proposal builds on the
PI's existing K01 project which aims to develop, implement, and test a novel implementation strategy to
improve the impact of USM through a combined implementation and effectiveness cluster randomized trial.
The goals of this R03 will be achieved through two aims: 1) Determine whether equity-focused implementation
of USM leads to increased uptake of meals by students at high risk of food insecurity and obesity, and 2)
Assess perceived acceptability and sustainability of equity-focused USM among students at high risk of food
insecurity and obesity. This evaluation will require merging several student-level datasets: meal participation
(primary outcome variable), food security, body mass index (BMI), demographic indicators (e.g., race, ethnicity,
income status), attendance, and dietary intake to create a food insecurity and obesity risk index and run multi-
level regression models to evaluate change in uptake among low, moderate, and high-risk participants. Aim 2
will require collecting qualitative interview data among students at varying risk for food insecurity and obesity
on perceptions of equity-focused implementation. This work will enhance the impact of the PI's existing K01 by
adding innovative student-level analyses, which will provide robust evidence on the impact of USM on socially
and economically marginalized populations. This R03 award holds significant potential for public health impact
and will provide preliminary data for Dr. McLoughlin to apply for a R01 award to test the resulting equity-
focused implementation strategy in a larger cluster randomized implementation and effectiveness trial.

Public health relevance
PROJECT NARRATIVE This study has the potential to positively impact public health by understanding the impact of equity-focused implementation of Universal School Meals (USM) among students most at risk for food insecurity and obesity. The grant proposes to test the impact of an implementation strategy on uptake of USM among students at low, moderate, and high-risk for food insecurity and obesity using both quantitative and qualitative methods grounded in the Consolidated Framework for Implementation Research (CFIR) and the Health Equity Measurement Framework (HEMF). This research project provides an innovate intersection of implementation science and health equity, addressing objective 6 of NHLBI to optimize clinical and implementation research to improve health and reduce disease.